The Patricia Levy Zusman International Workshop on Neuroregeneration at Houston Methodist

Project Summary/Abstract This R13 was conceived through discussions with investigators in the fields of neurostimulation and neuroplasticity at the Houston Methodist Research Institute (HMRI). In 2017, we held an R13-funded pilot workshop that combined research in neural stimulation with new insight into the molecular understanding of neural plasticity and regeneration. The results of said workshop indicated a strongly positive response by participants and interest in further catalysts of working collaboration. Thus, in 2019 we introduced new ways to increase relationship development and crossover opportunities among attendees, one of which was a blitz session wherein newly formed (i.e., established at the 2019 Workshop) collaborative teams competed for two $5K mini grants that supported travel to and from each other’s institutions. Given the overwhelmingly positive feedback, this will continue. On March 3rd-6th 2021, we will host the third Patricia Levy Zusman International Workshop on Neuroregeneration (Zusman Workshop) with a focus on the intersection of electrical activity, brain connectomics and molecular neural plasticity. Our specific aims are to: 1) formulate new ideas to fill the gap between physiology and functional-based brain stimulation technologies and the molecular and cellular understanding of innate neuronal plasticity; 2) integrate promising trainees into plenary sessions; and 3) ensure trainees participate in substantial discussions and interactions with faculty members. As in previous workshops, the 2021 Workshop will be held at HMRI. HMRI is part of the Texas Medical Center (TMC), a one-of-its-kind medical and research hub that fosters cross-institutional collaboration, creativity, and innovation located in one of the United States’ most diverse cities: Houston Texas. A key aspect of the Zusman Workshop is the active inclusion and participation of trainees, particularly women and under-represented minorities. We will encourage their participation through travel scholarships and via active promotion and recruitment throughout the TMC. Also, the Workshop seeks to promote the voices of graduate and postdoctoral trainees. As such, the 2021 Workshop will include several trainee poster sessions as well as a session dedicated to trainee presentations (given by travel awardees). Further, goal-oriented breakout sessions led by senior/early-stage investigators and selected trainees will foster discussion and promote cross-trainingand collaborationamong participants. Overall, the format of this workshop is distinct from established physiology conferences and dedicated neural regeneration conferences in several ways. It is: 1) highly focused on the gap between molecular regeneration and electrophysiology/stimulation, 2) concept driven by clinicians and experimentalists currently problem solving in human therapy, and 3) focused on the establishment of cross training and expertise development in graduate, post-graduate, and clinical fellows. We believe the 2021 Zusman Workshop will ignite collaborative networks between investigators and produce novel collaborative teams that will develop innovative, transdisciplinary methods, technologies, and treatments to modulate performance in the damaged nervous system.

Public health relevance
Project Narrative A large gap exists between researchers who seek to develop methods of neural plasticity and long-distance regeneration and experts who study the outcomes and safety of brain computer interfaces. Therefore, in 2017, we developed and held the first biannual Patricia Levy Zusman International Workshop on Neuroregeneration, which focused on the intersection of electrical activity, brain connectomics, and molecular neural plasticity. In 2021, our goals are to 1) build upon the success of our previous two workshops by inviting back and sponsoring travel for rising star alumni to return and participate; 2) create an interdisciplinary discussion of the gap in these disciplines, and 3) stimulate working groups, training opportunities, and translational approaches to speed progress in directed, stimulation-based regenerative therapies.